Detailed functional analysis of gamete recognition protein interactions

DESCRIPTION (provided by applicant): The identification of interacting male-female reproductive proteins is imperative for a molecular understanding of fertilization. Generally, the molecular descriptions have relied upon studies of male reproductive proteins. This research proposal is aimed at characterizing interacting male- female reproductive proteins in abalone, a system with for which many of the molecular details of fertilization are well established and one that serves as a model for the study of reproductive molecules and evolution of species-specific fertilization. Three specific aims relating to abalone are proposed: Aim 1. Biochemical analysis of interactions among gamete recognition proteins. Aim 2. Molecular description of VE supramolecular structure through analysis of ZP glycoprotein interactions. Aim 3. Abalone sperm proteome and functional analysis of a newly discovered novel gamete recognition protein. The research proposed is innovative in that it is highly integrative, utilizing genomic, proteomic, biochemical, and computational methods. This work will test for evidence of direct functional interactions between sperm and egg molecules. The functional specificity sperm-egg interaction will be further investigated. Together these research aims represent a significant advancement in our understanding of the molecular interactions between sperm and egg, the evolutionary dynamics of genes encoding sperm/egg proteins, and will contribute to a broader understanding of the function and evolution of reproductive genes.

Public health relevance
PUBLIC HEALTH RELEVANCE: The interactions between sperm and egg molecules during fertilization have proven elusive in studies of human reproduction. The model organism used in this study (abalone, a marine gastropod) shares a common molecular basis with vertebrates (including humans and other mammals), exhibits a common pattern of rapid divergence of sperm and egg proteins, and allows for experimental approaches not possible in other animals. Thus the proposed work addresses general themes in reproductive biology, and may shed light on the molecular basis of sperm and egg interactions of relevance to human reproduction.